Alterations & Renovations for Enhanced Phenotyping

Alterations and Renovations: Summary
The overall goal of the Center for Integrated Biomedical and Rural Health Research is to strengthen the
biomedical research infrastructure in Montana with a focus on the central, multi-disciplinary theme of Integrated
Biomedical and Rural Health Research. As noted throughout the application, integrated research is generally
defined as interdisciplinary research that incorporates, or integrates, basic and translational research with
anticipated applications, whereas rural health research is most often focused on equity and access to healthcare
more than on the development of new diagnostics and therapeutics. We propose to establish the Center for
Integrated Biomedical and Rural Health Research (CIB-RHR) as the only interdisciplinary research center in the
state of Montana to combine the basic and translational research strength of the only independent nonprofit
biomedical research institute in the state, with the training opportunities and research resources of the only
nonprofit medical school in the state, and the clinical strength of the largest comprehensive health provider
system in central Montana. The Alterations and Renovations, proposed here, are critical improvements to our
mouse phenotyping facilities, a central part of the translation of basic science to preclinical models and clinical
applications. The result is that we can optimize and expand services available within the Gene Editing and Mouse
Model Assessment (GEMMA) Core by adding a Gait Analysis system, which will be used by multiple COBRE
projects, and an in vivo bioluminescence and fluorescence imaging system that will accommodate current and
future COBRE projects and increase capacity for multidisciplinary basic and translational research across a
broad range of biomedical fields. To accommodate these upgrades for phenotyping, we renovate the space that
will house the expanded capabilities. Given the vital importance of mouse phenotyping to all of the proposed
COBRE projects and the long-term objectives of the GEMMA Core and the Center for Integrated Biomedical and
Rural Health Research, we propose Alterations and Renovations that will make significant improvements to our
mouse assessment facilities and ensure research rigor through more consistent and reproducible data.